Interrogating spatiotemporal control of mRNA in Drosophila morphogenesis using Cas13-based techniques

PROJECT SUMMARY/ABSTRACT
Establishing subcellular compartments and cell polarity requires asymmetric distribution of the proteome.
mRNA localization and onsite translation ensure that cells produce proteins at the right place and time, and this
regulation allows for asymmetric distribution of proteins for morphogenesis. In particular, the development,
maintenance, and function of neurons require posttranscriptional regulation as the complex and polarized
morphology necessitates the transport of mRNAs to neurites, which can be as long as a meter in animals.
Mutations in RNA binding proteins that regulate mRNA localization and onsite translation are associated with
neurological diseases, including amyotrophic lateral sclerosis, spinal motor atrophy, and fragile X syndrome. In
these diseases, mutations in RNA binding proteins are also associated with abnormal neuron morphology.
Despite the knowledge that neuronal morphogenesis requires proper mRNA localization, the mechanistic link
between spatiotemporal regulation of mRNA and morphogenesis remains unknown.
This proposal investigates the mechanistic link between spatiotemporal regulation of mRNA and neuronal
remodeling during morphogenesis. I will take advantage of Drosophila mushroom body and dendritic
arborization neurons as models of developmental neuronal remodeling, where early neuronal connections
degenerate and neurites are refined. Specifically, I will investigate spatial and temporal regulation of the
chickadee (chic) transcript during regrowth of dendrites in Drosophila class IV dendritic arborization neurons
and mushroom body γ neurons. I hypothesize that during the neurite extension phase of neuronal remodeling
of these PNS and CNS neurons, respectively, chic mRNA localizes to branch emergence sites where its cohort
of protein interactors changes to anchor the transcript and to alter translation rates. First, I will characterize
chic localization and motility during neuronal remodeling using a novel Cas13-based method for live imaging.
Second, I will identify proteins interacting with chic mRNA during neuronal remodeling using a Cas13-based
method for RNA-centric proximity labeling. CRISPR/Cas13-based methods are an exciting, novel approach to
probe endogenous RNA in live organisms and unlike established methods of probing RNA, they do not perturb
the transcript sequences. CRISPR methods are generally very precise, and the family of Cas13 proteins I will
use is highly specific. The results of this proposal will elucidate the role of spatiotemporal regulation of mRNA
in the regulation of gene expression needed for neuronal outgrowth. Additionally, I will establish Cas13-based
methods that can be used for investigating RNA for other biological questions and in other organisms.

Public health relevance
PROJECT NARRATIVE The regulation of gene expression to produce proteins at the right time and right place is essential for animal development. Localization of messenger RNA (mRNA) and local translation is one method of regulating gene expression posttranscriptionally, and this mRNA regulation is necessary for establishing asymmetrical protein distributions to create the architecture of polarized cells during a process called morphogenesis. This proposal examines the localization and protein interactors of an mRNA as neurons remodel their axons and dendrites during morphogenesis using a relevant fruit fly (Drosophila) model through novel CRISPR/Cas13-based methods.